Role of SARS-CoV-2-mediated Type I IFN antagonism in individuals with Down Syndrome

Project Summary Type I Interferons (IFN-Is) are cytokines with potent anti-viral and proinflammatory activities. As such they are tightly regulated to provide enough antiviral effects while not causing over and health disrupting inflammation. Disorders where IFN-Is dysregulation is known to cause pathology are termed type I Interferonopathies. Down syndrome (DS) is the most common genetic cause of intellectual and developmental disabilities in children and young adults with Incidence in US of about 1 in 600 individuals. Individuals with DS often have cardiac and gastrointestinal abnormalities. Additionally, they have a number of immune-related problems from increased susceptibility to an array of infectious diseases to autoimmunity. Unfortunately, the exact molecular mechanism leading to these immune defects has not been elucidated. COVID-19 is a disease caused by a coronavirus, Severe Acute Respiratory Syndrome (SARS) -CoV-2. Infections by SARS-CoV-2 are now present in every country around the globe, causing unprecedented public health burden. SARS-CoV is known to interfere with IFN-I induction and signaling. To which extent SARS-CoV- 2 can cause illness in individuals with DS is currently unknown. DS is, in most cases, caused by an extra chromosome 21, on which the receptors for type I Interferons (IFNAR1 and IFNAR2) are encoded. How this gene dosage effects are contributing to SARS-CoV-2 pathophysiology is not understood. This proposal is built around the hypothesis that relative amounts of IFNAR1 and IFNAR2 are the essential factors controlling SARS- CoV-2 pathophysiology. To address this hypothesis, we propose to study DS patients in vitro at the molecular level to determine the functional significance of dose of these genes in regulating IFN pathway in humans during SARS-CoV-2 infection. Deeper understanding of molecular regulation of IFN-I in DS in the context of SARS-CoV-2 will allow us to better understand how to approach clinical management of disease.

Public health relevance
Project Narrative Down syndrome is principally caused by trisomy of chromosome 21, resulting in extra copies of the interferon receptors, IFNAR1 and IFNAR2. Signaling through these IFN receptors to initiates the highly potent antiviral and inflammatory functions of the type I Interferons (IFNs) response. The purpose of this study is to understand how altered IFN receptor availability, as is the case in Downs syndrome individuals, impact the SARS-CoV-2 pathogenesis.